Understanding biased agonism in receptor tyrosine kinases to devise new modalities for their targeting in cancer

PROJECT SUMMARY/ABSTRACT
This project takes a unique dynamic view of signaling by receptor tyrosine kinases (RTKs), testing the
hypothesis that signaling specificity is kinetically defined, and that modulating dynamics might underlie a new
therapeutic approach. Advancing with these questions will require new microscopy-based approaches in living
cells – exploiting techniques that I have focused on throughout my career and taking advantage of the
Lemmon lab’s biochemical expertise. Despite decades of study, and their importance as therapeutic targets,
RTKs remain poorly understood mechanistically. Most RTKs dimerize upon ligand binding, and this is still
believed to be the key step in their activation. The prevailing simple ‘on/off’ view is inconsistent, however, with
the fact that RTKs can respond differentially to their multiple distinct activating ligands – displaying biased
agonism or functional selectivity. Recent work in the Lemmon lab suggests that this selectivity is kinetically
defined, with the life-time of the RTK’s activated state differing from ligand to ligand and defining the nature of
the signaling outcome. Testing this new hypothesis requires single-molecule analysis of receptor activation
kinetics in relevant cellular contexts. To date, kinetic arguments have only been inferred from structural and
indirect signaling studies. My proposal focuses on directly observing the kinetics of RTK signaling in living
cells. In particular, I will study the lifetime of different activated dimeric RTK states – and the resulting signaling
kinetics – for the epidermal growth factor receptor (EGFR) when bound to its 7 different activating ligands.
These studies will exploit advanced single-molecule fluorescence microscopy techniques in living cells that I
have been developing, and will also correlate the results with structural and signaling work.
My career goal is to obtain a research faculty position at a leading institute where I will continue to
dissect the mechanisms of RTK dimerization and signaling. My successful transition to independence in this
field would be significantly bolstered by augmenting my microscopy expertise with other biophysical and
structural techniques in both in vitro and in vivo systems. It is with these acquired skills that I will be able to
investigate how receptor dimerization dynamics define signaling specificity, and how they might be modulated
pharmacologically. The success of this project will be greatly enhanced by the outstanding collaborators that I
have assembled to advise me throughout my transition to independence. In addition, the exceptional research
environment at the Cancer Biology Institute and the Yale Medical school area has all the necessary resources
required for the proposed training and research studies. The K99/R00 would provide me with the protected
time needed for this advanced training and allow me to continue to foster my growth under the mentorship of
Dr. Mark Lemmon. I expect that the time provided by this award will allow me to elucidate the relationship
between receptor dimerization dynamics and signal specificity, and will illuminate new avenues for
pharmacological intervention.

Public health relevance
Project Narritive Oncogenic receptors like the EGF receptor have long been viewed as binary signaling molecules with an ‘on’ and ‘off’ state. As such, current cancer therapeutics are designed simply to block signaling, and shut off receptor activity. However, our recent findings suggest that altered timing of EGF receptor signaling plays a key role in cancer. This study focuses on studying these changes in timing, or kinetics, with a view to developing therapeutics that can ‘correct’ rather than simply block signaling of oncogenic receptors.